Improving understanding of sleep apnea pathogenesis using novel imaging techniques during sleep

ABSTRACT
OSA is a chronic condition characterized by recurrent complete (apnea) or partial (hypopnea) airway collapse
during sleep. Effective and long-term treatment is required to reduce the large public health burden associated
with OSA. A better characterization of the site and pattern of airway collapse and how upper airway anatomy
mediates this collapse would provide new insights into OSA pathogenesis and can guide optimal therapies,
particularly for the 30-50% of patients who cannot tolerate positive airway pressure (PAP) therapy (the first-line
treatment). Currently, our knowledge of the upper airway anatomy that increases risk for developing OSA is
largely based on magnetic resonance imaging (MRI) or computed tomography (CT) studies during wake.
However, visualizing the upper airway during sleep (concurrent with apneas) would allow us to develop more
mechanistic insights into how and why the upper airway narrows or collapses. One way to achieve this is through
drug-induced sleep endoscopy (DISE), a clinical procedure that simulates sleep with propofol. By examining
pressure-flow and pressure-area relationships during DISE, we are able to quantify the pressure required to
open (pharyngeal opening pressure [PhOP]) or close (critical closing pressure [Pcrit]) the airway and obtain key
insights into the pattern (anterior-posterior or lateral) and location (retropalatal or retroglossal region) of airway
collapse. While our approach to DISE is state-of-the-art, it is not able to visualize the movements by which
pharyngeal soft tissues and craniofacial structures mediate airway closure. However, dynamic MRI during sleep
can provide high resolution imaging of upper airway anatomy across multiple sleep stages and apneas. The
global hypothesis of this R01 is that the combination of state-dependent MRI and novel phenotyping from DISE
will provide new insights into the mechanisms of upper airway collapse during apneas by identifying the anatomic
structures that mediate segmental airway collapse and providing key information on regional airway compliance
and closing pressures. Aim 1 will use state-dependent MRI to determine (1A) the site, pattern and magnitude of
airway collapse during sleep, (1B) the anatomical movements that mediate retropalatal and retroglossal airway
collapse, and (1C) whether these pharyngeal changes differ by sleep stage. Aim 2 will use novel methods during
DISE to (2A) objectively quantify airway collapse, (2B) perform pressure-area analysis to measure regional
compliance of specific pharyngeal segments, and (2C) use pressure-flow relationships to quantify PhOP and
Pcrit. Aim 3 will combine data in Aims 1 and 2 to examine the mechanisms of airway collapse during sleep,
including if characteristics of collapse on DISE and MRI agree and how compliance and pressure-flow
relationships on DISE differ based on the MRI sleep-related movement of pharyngeal structures. Aim 4 will
explore the ability to predict successful response to clinically-indicated upper airway surgery for OSA using these
imaging modalities. Overall, this project utilizes a multidisciplinary approach to elucidate state-dependent
mechanisms of upper airway collapse by linking anatomic changes with alterations in airflow dynamics.

Public health relevance
LAY NARRATIVE Obstructive sleep apnea (OSA) is a very common condition that carries a high public health burden due to its association with multiple adverse outcomes, including cardiovascular disease and daytime sleepiness. More mechanistic insights into how and why the upper airway collapses in patients with OSA is important for guiding personalized therapies, particularly for the many patients who cannot tolerate positive airway pressure therapy (the recommended first-line treatment). This proposal focuses on providing these insights through the application of novel imaging techniques performed during sleep.